Modulation of pain mechanisms by cannabis-derived phytochemicals.

PROJECT SUMMARY/ABSTRACT
Chronic pain – often arising from musculoskeletal injury, neurological dysfunction, cancer, or autoimmune disorders –
affects ~100 million Americans. Overreliance on opioid analgesics has resulted in a national public health crisis in which
opioid overdoses have claimed over 47,000 lives in 2017 and are now the leading cause of avoidable deaths in the nation.
The Cannabis plant has analgesic and anti‐inflammatory properties owing to its rich content of cannabinoids, terpenes,
lignans, and flavonoids. However, research on the biological effects and molecular mechanisms of the numerous bioactive
phytochemicals – alone or in combination (entourage effect) – has been limited. We have assembled a complementary
and interdisciplinary team that combines expertises in molecular and cellular signaling, ion channel biology, natural
products chemistry, and molecular pharmacology as well as all aspects of endocannabinoid biology. Our preliminary high‐
throughput screening (HTS) bioassays have identified several cannabinoids that inhibit calcium signaling in immune
cells and may therefore reduce inflammation and the associated pain. Results from the work proposed here will identify
the anti‐inflammatory molecules contained in Cannabis sativa and characterize the mechanisms of action they engage.
We hypothesize that specific phytochemicals in Cannabis suppress cellular Ca2+ signaling and subsequent release of pro‐
inflammatory cytokines in immunocytes that contribute to inflammatory pain. We further hypothesize that combinations
of Cannabis phytochemicals synergistically inhibit certain ion channels and G protein‐coupled receptors involved in
immunocyte Ca2+ signaling and cytokine release, thereby ameliorating inflammatory pain.
We propose to perform pharmacological profiling of individual and entourage effects of Cannabis phytochemicals on
Ca2+ signaling in 5 specific pro‐inflammatory human immune cells (Aim 1A). We will determine the cellular and molecular
Ca2+ mobilizing mechanisms engaged by active Cannabis phytochemicals in these immune cells (Aim 1B); and profile
Cannabis phytochemicals on established molecular targets of nociceptive, inflammatory and neuropathic pain (specific
TRP channels and G‐proteins) using heterologous expression systems, HTS bioassays and single cell electrophysiology (Aim
1C). In Aim 2 will assess analgesic properties of active cannabinoids and combinations using in vivo mouse models of
inflammatory and neuropathic pain. Here, we will first determine in vitro “Absorption, Distribution, Metabolism, and
Excretion” (ADME) properties (Aim 2A) and in vivo pharmacokinetics (Aim 2B) of said cannabinoids. We will then assess
the most favorable cannabinoid(s) in Complete Freund's Adjuvant (CFA)‐induced inflammation and paclitaxel‐mediated
toxic neuropathic pain (Aim 2C).
Together, these studies will create a comprehensive and mechanistic knowledge base about the efficacy, potency and
suitability of Cannabis‐derived phytochemicals as anti‐inflammatory analgesics and may contribute to ameliorating the
current opioid epidemic.

Public health relevance
PROJECT NARRATIVE Chronic pain – often arising from musculoskeletal injury, neurological disease, cancer, or autoimmune disease – affects ~100 million Americans. There is growing evidence that the plant Cannabis sativa has analgesic and anti‐inflammatory properties without the detrimental side effects seen by opioid use. Our studies will find the ingredients in Cannabis that reduce inflammation and chronic pain, which may help abate the nation's opioid epidemic.